Comprehensive characterization of parasite and commensal assemblages in humans

PROJECT SUMMARY/ABSTRACT
Diseases attributed to parasites cause substantial morbidity and mortality globally. However, there is mounting
evidence that the relationship between humans and symbionts (defined here as all host-dependent eukaryotic
organisms, including parasites and commensals) is not always detrimental and, in fact, may sometimes confer
important health advantages. Symbiont assemblages may aid in digestion, confer protective immunity, or,
paradoxically, provide protection from pathogenic parasite infection and disease. We currently understand the
biology and ecology of eukaryotic parasites that cause human disease, but we know very little about the overall
structure and function of communities of protozoans and helminths that also colonize humans. This
shortcoming hinders progress in the field of parasitology, compared to the fields of bacteriology and mycology,
which have revolutionized our understanding of human health through the study of bacterial and fungal
microbiota. Indeed, most current parasitological methods are designed for a different purpose: to target
specific, pathogenic organisms. Although methods for unbiased community analysis have been validated and
standardized for prokaryotes and fungi, no such methods currently exist for eukaryotic symbionts, including
parasites. With no standardized methods in place, research into the beneficial effects of eukaryotic
symbiont communities and their potential role in parasitic disease represents a critical knowledge gap.
The ultimate objective of this work is to create a uniform, validated research tool for the study of
human symbiont assemblages, comparable to what has been achieved for the bacterial and fungal
microbiomes. To this end, we have developed a novel comprehensive (able to identify all organisms
regardless of prior characterization, including novel organisms) assay for eukaryotic symbiont assemblage
characterization that is based on newly-designed PCR primers, a novel noise reduction strategy, and a user-
friendly bioinformatic pipeline. Our goals in developing this assay were to 1) create an “industry standard” for
symbiont community assessment, analogous to other standardized microbiome assays, 2) develop a broadly-
applicable research method useful for all organisms and all sample types, 3) contribute to our understanding of
the basic biology and ecology of human eukaryotic symbiont communities and 4) inform future development of
“universal” diagnostic tools and targeted anti-parasitic therapeutics. We will optimize the assay in silico using
custom databases, in vitro using a “mock community”, and ex vivo using samples from experimentally-infected
animals. We will then validate the pipeline and assess its performance by analyzing human samples from two
different populations in which intestinal parasites have previously been characterized by microscopy and PCR.
Through completion of this project, we hope to provide a critically-needed research tool that will improve our
understanding of human symbiont communities, and that, in turn, will inform advances in human health and
medicine.

Public health relevance
PROJECT NARRATIVE This project aims to optimize and validate a novel, high-throughput, metabarcoding-based method for the comprehensive (able to identify all organisms in a sample regardless of prior characterization) assessment of communities of eukaryotic symbionts (all host-dependent organisms, including parasites and commensals) that is universal (effective for any vertebrate host and any sample type- including fecal, tissue, blood, or culture). We expect that this project will have widespread impact on research and diagnostics and will advance 1) our knowledge of the basic biology of symbiont communities and the interactions between parasites and commensals, 2) our understanding of the role of commensals in maintaining human health and preventing disease, 3) the utility of comprehensive diagnostics and directed therapies for parasite infections that target pathogens while maintaining potentially-beneficial organisms.